Molecular Simulations of Folding & Association in Physiological Environments

Recent advances in the field of structural biology and quantitative proteomics mean that there is now sufficient information available to allow the construction of meaningful, working molecular models of physiological environments. Such environmental models, when coupled to simulation methods that enable the dynamics of the systems to be modeled, will allow key biochemical processes such as protein folding and protein-protein association events to be observed in settings that much more closely mimic those encountered in real life. The project proposed here has two major objectives which will be pursued in parallel: (1) molecular simulation methods that have been under development in the PI's laboratory for some years will be extended and accelerated to make them suitable for use in simulating the dynamics of very large-scale macromolecular systems (e.g. comprising 10,000 macromolecules), (2) structural biological and quantitative proteomics data will be utilized to build preliminary 3D models of four different environments in the model prokaryote Escherichia coli: the cytoplasm, periplasm, and inner and outer-membranes

Public health relevance
PROJECT NARRATIVE Understanding the molecular processes that define life, and the way that these processes can be altered in disease states and under the influence of drugs, may ultimately require a true molecular level picture of intracellular events to be obtained. The proposed research aims to combine recent advances in the fields of structural biology and quantitative proteomics to build working, molecular models of physiological environments, such as those found inside the bacterium Escherichia coli. Observing key processes such as protein folding and associations occurring in situ may have the potential, eventually, of leading to new avenues for therapeutic intervention.